Forebrain Representations and Control of Sniffing

Project Summary / Abstract
Sniffing is an adaptive behavioral strategy to actively sample the olfactory environment. It is crucial to a broad
range of functions including finding food, avoiding predators, and recognizing conspecifics. Common to all
terrestrial vertebrates, sniffing guides exploration and navigation by co-opting the neural machinery for
breathing and increasing the breathing rate to pass air through the nasal cavity and past olfactory receptors.
Despite its ubiquity, relatively little is known about the neural control of sniffing. Evidence suggests the
forebrain impinges on the brainstem circuitry responsible for basal breathing to modulate the rate and depth of
breathing, as is also thought to occur during vocalizations. Based on a wealth of anatomical and functional
data, we hypothesize the hippocampus and entorhinal cortex are crucial nodes in the forebrain control of
sniffing, establishing an associative link between olfactory sensory information and sniffing motor control to
achieve navigational goals. In Aim 1, we will explore how breathing information is projected to the
hippocampus by way of a respiratory corollary discharge. Using in vivo electrophysiological recordings in
hippocampus and entorhinal cortex, along with optogenetic silencing of identified projection neurons, we seek
to identify regions involved in transmitting an efference copy of the breathing rhythm to hippocampus. In Aim 2,
we will determine the role of the hippocampus in the initiation of sniffing. Recent evidence implicates regions
downstream of hippocampus in the initiation of exploratory behaviors, including sniffing. By using transgenic
mouse lines and optogenetics, we will identify neurons in the hippocampus involved in promoting sniffing
during active exploration of a novel environment and in an olfactory-guided navigation task. By using modern
tools in in vivo electrophysiology and genetic biotechnology, along with cutting-edge machine learning and
behavioral analysis, we seek to understand how the hippocampus combines disparate information streams to
guide navigational decisions, including the decision to sniff. Overall, these experiments will reveal a role for the
hippocampus in a critical adaptive behavior and provide insight into the mechanisms through which the
forebrain exerts control over low-level motor controllers and pattern generators.

Public health relevance
Project Narrative Almost all terrestrial vertebrates sniff, actively passing air and odors through the nasal cavity, as a primary means to navigate and explore the world. This work aims to understand how the hippocampus, a forebrain region crucial to navigation and memory, is involved in sniffing as means to sample information and guide behavior. Results from this study will contribute to our understanding of a complex brain-wide circuit that controls a ubiquitous adaptive behavior.